Omics, Bioinformatics, and Data Management Core

CORE D PROJECT SUMMARY
The `Omics, Bioinformatics, and Data Management Core (Core D) serves this Program by providing high
resolution functional genomics and bioinformatics computation analyses with statistical integration. The main
objective of the Core is to define the gene expression signatures and their functional output that program the
immune response for 68-1 RhCMV/SIV vaccine mediated SIV replication arrest in pre-clinical rhesus macaque
(RM) vaccine studies. The Core will interrogate single CD8+ T cells in blood and tissues, their linkage of specific
T cell receptor usage (to identify SIV-specific clonotypes), single non-CD8+ T cells in blood and tissues, and
whole immune tissues including whole blood, lymph node (LN), spleen, bone marrow (BM) and gut-associated
lymphoid tissues (GALT), and will link data sets with spatial transcriptomic data sets, to define gene expression
signatures and networks, and will apply cutting edge bioinformatics approaches to model their functional output
and inform the mechanisms of action by which RhCMV/SIV vaccination programs the immune response for
replication arrest-type protection against SIV infection. To meet these goals, Core D will address the following
Specific Aims: 1) provide specialized CITE-seq and/or TCR sequence identification using the 10X Genomics
platform, 2) conduct Nanostring and bulk RNAseq analysis of whole blood and tissues, 3) provide bioinformatic
and biostatistical analyses, and computational modeling, to define immune response gene expression signatures
linked with vaccine actions and virus control, and 4) develop and manage a comprehensive database for all
Program data to facilitate integrated data analysis. Core D is directed by Dr. Michael Gale, Jr., working closely
with Drs. Ben Bimber and Paul Edlefsen, to provide consistent, high-quality functional genomics data generation,
integrated data analysis, biostatistical analyses and computational modeling, with big data management, for all
aspects of the scientific program.